The role of LRRK2 in pancreatic beta cell responses to inflammatory damage

Abstract
This F31 proposal describes a comprehensive training and mentorship program for Belle Henry, a Ph.D.
candidate in the Immunology program at the University of Michigan. Ms. Henry will participate in a rigorous
didactic and laboratory training curriculum, supervised by her mentor as well as support from a multi-disciplinary
mentorship and dissertation committee. Her training program will include supervised molecular, structural, and
biochemical training, as well as mentored opportunities to engage in scientific writing, presentations, and grant
applications. The ultimate goal of this proposal is to best position Ms. Henry for an independent and productive
scientific career. Diabetes is a global epidemic of increasing prevalence, where all forms of diabetes are linked
by insufficient β-cell function or mass to meet peripheral insulin demands. Type 1 diabetes (T1D) is caused by a
combination of both intrinsic β cell dysfunction and dysregulation of the immune system, thus leading to
autoimmune attack and β cell demise. As β cells are uniquely sensitive to inflammatory damage, therapies
targeting the β cell present opportunities for treatment of T1D. The long-term objective of my project is to
better understand the molecular mechanisms that govern β-cell responses to inflammatory challenge and gain
greater insight into the mechanisms that regulate β cell survival. My project focuses on the β-cell-specific role of
leucine-rich repeat kinase 2 (LRRK2), a kinase that phosphorylates Rab GTPases to regulate membrane
trafficking. My preliminary data indicate that LRRK2 is transcriptionally induced in β cells following cytokine
exposure, and pharmacologic inhibition of LRRK2 protects β cells against pro-inflammatory cytokine-induced
death. The overall objective of my project is to understand the role of LRRK2 in β-cell responses to
inflammatory toxicity. LRRK2 has been shown to regulate mitophagy in other cell types, and previous work from
the Soleimanpour lab demonstrates that β cells regulate mitochondrial turnover to promote cell survival in pro-
inflammatory contexts. Thus, I hypothesize that in response to inflammatory damage, LRRK2 modulates β cell
survival through regulation of mitophagy, which I will test through 2 Specific Aims. Aim 1 will determine the
importance of LRRK2 to β cell function and survival in mouse models of β cell inflammation and primary human
islets. Aim 2 will elucidate the mechanistic impact of LRRK2 induction on mitochondrial quality control following
inflammatory damage by examining its role in mitophagy. Successful completion of these Aims will provide novel
and critical insights into the mechanistic responses of β cells to inflammatory stimuli that could be targeted to
defend β-cells to treat or prevent diabetes.

Public health relevance
Project Narrative Diabetes affects over an estimated 422 million individuals globally and nearly 1 in 10 Americans, yet the causes of diabetes are still poorly understood. Our mission is to assess how genetic changes can alter the ability of insulin-producing pancreatic β-cells to respond to inflammatory stress, ultimately resulting in β-cell damage and dysregulated blood sugar. We hope that our findings will provide new insights into the source of diabetes development.